The Oxygen Sensing Mechanism in Retinal Endothelial Cells as a Novel Target to Suppress Ischemic Neovascularization

Project Summary
Proliferative diabetic retinopathy (PDR) is a leading cause of blindness in adults, mostly due to
neovascularization in ischemic and hypoxic retinal tissues. While monthly injection of anti-VEGF provides relief,
it is associated with major side effect such as retinal detachment, and over a third of the patients are refractory
to the antibody treatment. The long term objective of this project is to investigate how the endothelial oxygen
sensing mechanism regulates retinal angiogenesis, and develop novel strategies to curb neovascularization in
ischemic retinal tissues. Typically, hypoxia drives angiogenesis by paracrine mechanisms wherein hypoxia-
inducible factor-α proteins upregulate the expression of angiogenic factors, which activate their cognate
receptors on nearby endothelial cells (EC). In well oxygenated tissues, HIF-α proteins degrade rapidly
following oxygen dependent prolyl hydroxylation by prolyl hydroxylase domain containing proteins (PHD1,
PHD2, and PHD3). Thus, deficiency in PHDs mimics hypoxia at the molecular level by allowing HIF-α proteins
to accumulate. Indeed, our published studies demonstrate that post-natal PHD2 deficiency globally or in non-
endothelial cells promotes vascular growth or survival. In recent Preliminary Studies, we made a rather
unexpected observation that EC specific PHD2 deficiency (Phd2EC-/-) inhibited instead of promoting retinal
vascular development, despite high level accumulation of HIF-1α and HIF-2α. On the other hand, Flt-1 was
upregulated, which is known to sequester VEGF-A. In the mouse model of oxygen-induced retinopathy (OIR),
a proxy of PDR as well as ROP (retinopathy of prematurity), Phd2EC-/- mice also displayed greatly reduced
neovascularization. These findings led to our Central Hypothesis stating that retinal angiogenesis is
dynamically regulated by two opposing oxygen sensing mechanisms: in the cells of the retinal parenchyma,
hypoxia activates angiogenesis by HIF- dependent expression of angiogenic factors; whereas in the retinal
ECs, hypoxia inhibits angiogenesis by upregulating anti-angiogenic molecules such as Flt-1. Aim 1. Investigate
how the endothelial oxygen sensing mechanism regulates retinal vascular development. Examine whether EC
specific deletion of HIF-1α, HIF-2α, or Flt-1 rescues retinal vascular development in Phd2EC-/- mice; whether
the accumulation of oxygen resistant but otherwise normal HIF-1α and HIF-2α suppresses angiogenesis; and
whether HIF-1α and HIF-2α directly interact with Flt-1 regulatory elements; Aim 2. Investigate whether the
oxygen sensing mechanisms regulating developmental angiogenesis also operate during ischemic
neovascularization in the OIR model. Aim 3. Test lentiviral vector-mediated anti-angiogenesis strategies.
Lentiviral vectors will be constructed that express PHD siRNAs or membrane - anchored truncated Flt-1 (tFlt-1),
all spatially restricted to retinal ECs and likely further restricted to ECs in ischemic retinal locations. The ability
of these vectors to suppress ischemic retinal neovascularization will be evaluated in the OIR model. These
studies may potentially lead to an innovative therapy to suppress neovascularization associated with PDR.

Public health relevance
Narratives Proliferative diabetic retinopathy (PDR) is a leading cause of blindness in adults. Despite recent progress in treatment, major side effects are still a significant concern, and a large fraction of patients do not respond to most advanced therapies. A major pathological mechanism of PDR is rampant growth of abnormal blood vessels in the retina, leading to leakage of blood contents, retinal tissue damage, and eventually loss of vision. This project is designed to gain insights into the mechanisms controlling retinal vascular growth, and develop novel therapeutic strategies to curb ischemic retinal neovascularization. These studies are carried out with the long term objective of improving PDR treatment.